Prelimbic cortex contribution to ethanol seeking in chronic neuropathic pain

Project Summary
Chronic pain and alcohol use disorders (AUD) are highly comorbid. People with chronic pain have an increased
likelihood to develop AUD than those without. Further, chronic pain and high pain intensity are associated with
elevated risk for relapse to alcohol use. Despite this, there is limited preclinical data on the neurobiological
substrates underlying relapse in the context of chronic pain. People with chronic pain report using alcohol to
alleviate pain and the accompanying psychosocial stress, which likely engages distinct neurocircuits to regulate
reward seeking. Our previous data in the spared nerve injury model of chronic neuropathic pain demonstrate
that ethanol effectively reduced allodynia – a hallmark symptom of chronic neuropathic pain – in both male and
female mice. Our preliminary data further identified facilitated pain-induced reinstatement of ethanol seeking in
a conditioned place preference model in males with chronic pain as compared to their sham injured counterparts.
The prelimbic cortex (PL) – a subregion of the medial prefrontal cortex – is a common substrate in the regulation
of ethanol seeking and pain. The PL and its outputs are key regulators of reinstatement of reward seeking, a
model of relapse-related behavior. The PL also mediates both affective and cognitive components of chronic
pain in rodent models and is highly disrupted in patients with chronic neuropathic pain. This makes the PL a
promising target in investigation of ethanol seeking and reinstatement under conditions of chronic pain. Thus,
experiments in this proposal will test the overarching hypothesis that chronic pain alters ethanol relapse-
related behaviors and associated neurobiological substrates, with a focus on the PL and its subcortical
projections. To test the hypothesis that chronic neuropathic pain alters PL activity during relapse-related
behavior, Aim 1 will combine in vivo electrophysiology with behavioral analyses to investigate PL activity during
the acquisition and expression of ethanol conditioned place preference and pain-induced reinstatement in adult
male and female mice with a spared nerve injury. Further, as we have demonstrated that ethanol is antiallodynic
in the spared nerve injury model, the effect of ethanol on PL activity surrounding painful stimulation will be
characterized. Aim 2 will test the hypothesis that discrete PL projections regulate reinstatement of ethanol
seeking. We will use chemogenetics to silence PL projections to the nucleus accumbens core or basolateral
amygdala, with the expectation that projections to the basolateral amygdala are necessary for pain induced
reinstatement but not ethanol-primed reinstatement in the context of chronic pain. Together, these experiments
will provide insight into the unique neurobehavioral niche mediating ethanol seeking and relapse-related behavior
under conditions of chronic pain. We expect that completion of this proposal will serve as a scaffold for
subsequent research into the neurobiological substrates of ethanol seeking.

Public health relevance
Project Narrative Chronic pain and alcohol use disorders are highly comorbid conditions with a complex, bidirectional relationship. Relapse to alcohol use is associated with increased pain, but therapeutics to reduce relapse risk in the context of chronic pain are lacking. Experiments in this proposal will use a rodent model of chronic pain to investigate the role of discrete neural circuits in the regulation of alcohol relapse-related behavior in animals with chronic pain.